Diversity Supplement for Real-time Wideband Cardiac MRI for Patients with a Cardiac Implantable Electronic Device

Project Summary/Abstract: Motivated by an unmet need to increase the value of cardiac imaging in our
healthcare system, this proposal seeks to improve the quality and expand the applicability of cardiovascular
MR (CMR) for patients with a cardiac implantable electronic device (CIED). CMR delivers better value than
other cardiac imaging modalities (SPECT, echocardiography) because patients with a CIED often have
underlying structural heart disease and require complex downstream clinical decisions (new or worsening
symptoms, VT ablation, battery replacement, CRT upgrades). As a versatile modality, CMR is capable of a
comprehensive evaluation including function, perfusion, flow, and scar. Beyond diagnosis, CMR has been
shown to predict major adverse cardiac events (MACE) in both ischemic (ICM) and non-ischemic
cardiomyopathies (NICM) and to afford guidance for electrophysiologic (EP) procedures. Unfortunately, due to
severe image artifacts induced by CIEDs and, to a lesser extent, arrhythmia and/or inability to perform breath-
holding during imaging, over 3 million Americans with a CIED may not benefit from a standard CMR.
To bridge this gap in cardiac imaging, we propose to combine and apply two cutting-edge, CMR technologies:
(1) wideband pulse sequences that are capable of suppressing image artifacts induced by implantable
cardioverter defibrillators (ICDs) and (2) compressed sensing (CS) accelerated real-time sequences that are
capable of achieving insensitivity to arrhythmia and breathing motion. The scientific premise is supported by
our experience (>9 years) in developing and translating wideband and CS. By leveraging our expertise in
wideband CMR and resources in CS supported by R01HL138578 & R21EB024315, we have assembled a
unique suite of real-time wideband CMR pulse sequences together with inline image reconstruction methods
for imaging patients with a CIED. Comprehensive real-time wideband CMR combining evaluation of ventricular
function, perfusion, valve function, and scar for assessing new or worsening cardiovascular symptoms will
reduce 47% in cost ($1185.67 medicare reimbursement technical and reading fees) and 91% in scan time (25
min) compared to current clinical practice requiring a combination of SPECT ($1544.80, 4 hours) and
echocardiography ($707.96, 25 min). For added value, myocardial scar burden assessed by CMR would be
useful for predicting MACE and guiding EP procedures in patients with a CIED.
The specific aims of this proposal are to: (1) validate real-time wideband CMR methods with a CIED against
clinical stress CMR without a CIED, (2) determine whether myocardial scar burden assessed with real-time
wideband CMR predicts MACE in patients with an ICD, and (3) determine whether scar assessed with
wideband CMR is strongly correlated with scar assessed with electroanatomic mapping. This proposal has
high impact potential because the proposed real-time wideband CMR technology would be broadly applicable
as a single diagnostic/prognostic/pre-procedural test for a growing number of CIED patients in the US, thereby
increasing the value of cardiac imaging for this cohort.

Public health relevance
PROJECT NARRATIVE: Over 3 million Americans who have a cardiac implantable electronic device (CIED) may not benefit from a standard cardiac MRI, because of severe image artifacts induced by CIED, heart rhythm disorders, and/or difficulty with breath-holding during imaging in this patient population. We have developed a unique suite of novel cardiac MRI methods that is capable of producing high-quality, artifact-free images of patients implanted with a CIED for diagnosing new or worsening symptoms of heart disease, predicting the likely course of heart disease, and guiding therapy. The long-term goal of this proposal is to increase the value of cardiac imaging in our healthcare system by improving the quality and expanding the applicability of cardiac MRI for patients with a CIED.